The role of intermittent binge ethanol, sex, and age on memory and CREB binding protein (CBP) expression

Summary
In humans, adolescence is a critical developmental period marked by increased risk-taking behaviors, brain
maturation, and cognitive development. Alcohol is highly consumed as an easy drug for most underage
drinkers to obtain. The early age of drinking increases one’s risk of alcohol abuse and dependence later in life
and can lead to lasting changes in protein expression and behavior. Adolescents have an altered sensitivity to
alcohol likely due to their ongoing development, showing decreased sensitivity to the negative effects while
having increased sensitivity to the rewarding effects as compared to adults. This difference in development
may further promote alcohol drinking in adolescents, resulting in long-lasting changes that are more severe
than in adults. Alcohol consumption has resulted in changes in protein expression and memory impairments
observed in both adults and adolescents. Two known proteins involved in memory are cAMP-response
element binding (CREB) protein and CREB binding protein (CBP). CBP is a histone acetyltransferase,
coactivator/cofactor for many transcription factors including CREB, and necessary for both short term and long-
term memory. The hippocampus and prefrontal cortex are two brain regions that undergo maturation changes
during adolescence and play a role in memory. Sex is also known to play a role in memory and studies have
suggested women may be more sensitive to the effects of alcohol. Given the lasting impact alcohol can have
on behavior and the brain, further understanding the persistent effects of alcohol due to sex and age is
important for the literature and further treatment possibilities. Our lab has shown ethanol to differentially impact
memory 3 weeks after the last dose, with an observed deficit in the novel object recognition task in adolescent
treated mice but not adult treated mice. Furthermore, we found several genes related to CRE, CREB, and CBP
were decreased due to ethanol following microarray analysis. This proposal will investigate the effects of sex,
ethanol, and developmental age on memory and CBP protein expression using behavioral and molecular
assays in DBA/2J mice. Aim 1 will investigate the impact of binge ethanol on ethanol metabolism, spatial
memory, and cognitive flexibility in male and female mice treated with ethanol in adolescence and adulthood
using blood ethanol concentration and the Barnes Maze task. In Aim 2, I will assess the level of protein
expression of CBP and other proteins that interact with CBP or are involved with CRE/CREB using westerns. I
will also assess CBP protein interactions using co-immunoprecipitation coupled with mass spectrometry.
Finally, in Aim 3 I will test the sufficiency of CBP using viral vectors in mice following the adolescent binge
ethanol procedure to assess the impact on the previously mentioned memory tasks. The combination of these
behavioral and molecular studies will provide useful knowledge to the literature addressing the gap regarding
developmental age, sex, and ethanol in memory and the CBP pathway.

Public health relevance
Project Narrative Alcohol is a commonly abused drug consumed during the critical developmental period of adolescence. Disturbances during this period of brain development can lead to long-lasting cognitive and protein expression changes. This proposal will characterize ethanol metabolism, cognitive behaviors, protein expression, and binding interaction alterations due to binge ethanol, sex, and developmental age, in addition to testing a therapeutic method to alleviate our previously observed memory deficit.